Core A: Administrative Core

Project Summary: Core A, Administrative Core
The Administrative Core will serve as the organizational foundation for research activities of the Udall
Center, and play a critical role in ensuring that the Center will be both a national leader in and local resource
for PD research. The Core will ensure that the Udall Center is a resource for career enhancement of Udall
Center investigators and an effective organizer of periodic, Udall Center-specific outreach activities for the local
and national PD patient/advocacy community. The Administrative Core is directed by the Program Director, Dr.
Standaert. He is assisted by the Program Administrator, Ms. Katherine Belue.
The primary mission of the Administrative Core is to promote the integration and function of the Udall
Center components and activities, and provide the infrastructure required for Center communication, decision-
making and administration and the activities of the Program Director. The Core will support and organize
periodic meetings of the Center Executive Committee, project staff, Internal Advisory Committee, External
Advisory Committee, and collaborators. The Core will ensure that all components of the Alabama Udall Center
maintain compliance with NIH policy requirements, and will prepare and submit annual progress reports for the
Udall Center, and coordinate attendance of the Center Director, Center Administrator, and Project and Core
Leads at the annual Udall Centers meeting.
The Core is responsible for coordinating activities that fulfill the Udall Center Mission Statement for
Training: “Training for physicians, scientists and the community today to accelerate progress in PD research
and treatment, and education to develop the scientific workforce and community partnerships of the future.”
The Core seeks to enhance the integration of the Alabama Udall Center with UAB internal Parkinson
disease research programs, promote the integration of the Alabama Udall Center with other Udall Centers and
national programs in PD research, and develop and conduct outreach activities for the local and national
Parkinson community, including an annual Udall Center symposium to present research results to the local
community. The Core will support the Udall Center web site and social media outreach.
The Core will maintain an accounting of resource generation and related utilization, and steps taken to
maximize the research utilization of these resources within and beyond the Udall Center. The Core will
coordinate data and resource sharing both between Udall Center investigators and with other Udall Centers
and outside investigators and organizations. The Core will coordinate interactions of the Udall Center with
NINDS staff, including providing advance notice of manuscripts and publications to the NINDS program officer
and working with the NINDS Office of Communications and Public Liaison on press releases highlighting
Center accomplishments.